Elucidating social competence: neural mechanisms for competition and cooperation

TITLE: Elucidating social competence: neural mechanisms for competition and cooperation
ABSTRACT
The ability to shift social behavior based on available information, known as social competence, is vital for social
animals’ group cohesion and survival. Deficits in social competence are a hallmark of neuropsychiatric disorders
such as autism spectrum disorders, major depression, and schizophrenia, significantly impairing patients' quality
of life. Past neuroscience research has largely failed to capture the dynamics of behavioral shifts because it has
primarily isolated and studied one type of behavior. Furthermore, most past research has ignored the social
factors that may influence behavioral changes. Competition and cooperation are two evolutionarily intertwined
social behaviors that are crucial for social competence and group survival across species. Past studies show
that the prefrontal cortex is important for competition and cooperation, but these behaviors have been mostly
studied in isolation limiting our understanding of how neural computations shift behavior. This project aims to fill
this gap by combining optical methods, chemogenetics and machine learning to investigate the role of the
prelimbic cortex (PL) and its projections to the lateral hypothalamus (LH) and basolateral amygdala (BLA) in
modulating both competitive and cooperative behaviors. We hypothesize that these two PL subpopulations are
part of a network that shifts behavior towards competition or cooperation depending on the context. Using our
novel behavioral tasks for mice, we can study a wide array of behavior states, including high competition, low
competition, selfish choices, cooperative behavior, and shifts between cooperative and competitive states. In
Aim 1 we will record the same PL-BLA or PL-LH neurons across cooperative and competitive states and identify
how they encode behavioral shifts in these states. In Aim 2 we will turn to multi-site electrophysiology to record
local field potentials from the PL-LH-BLA network simultaneously to study how network level activity encodes
behavioral shifts between competition and cooperation. In Aim 3, we will investigate the causal roles of PL-LH
neurons, PL-BLA neurons and reciprocal projections from BLA and LH to PL in competition and cooperation. The
findings will advance our understanding of the prefrontal mechanisms that govern adaptive social behaviors and
may inform therapeutic strategies to enhance social functioning in neuropsychiatric disorders.

Public health relevance
PROJECT NARRATIVE This project seeks to understand how prefrontal circuits shift social behaviors when appropriate, specifically focusing on the shifts between competition and cooperation. These social behaviors are essential for thriving and surviving yet social dysfunctions are a hallmark of many psychiatric disorders. Understanding how the brain controls social behaviors will facilitate development of novel treatments for social dysfunction.